Global Ophthalmology Summit

PROJECT SUMMARY
Global Ophthalmology is an expanding field within ophthalmology that unifies the local and international
community to advance research, clinical care, education, and policy to prevent blindness worldwide. The
Global Ophthalmology Summit is the only United States (U.S.) based meeting that delivers in depth and
focused content in research in global eye health and health equity. It brings together leaders to create
community and foster collaboration amongst meeting participants which is an opportunity to captivate a young
audience to lay the foundation for future collaborations, mentorship, and inspire a career in vision science. Key
research topics addressed include global scale collaborative research consortia, disease-specific interventions,
technology and innovation, sustainability, education, and advancing eye health systems in the U.S. and
globally. The resources sought in this proposal aim to enhance the participation of young researchers within
the field of global ophthalmology through the following aims. In aim 1 we want to provide an opportunity to
strengthen the global eye research community by bringing local and international expertise together to focus
on innovative solutions to prevent and treat blindness worldwide. In aim 2 our goal is to create collaboration
through providing intentional meeting content amongst the diverse group of attendees. In aim 3 we want to
support innovative vision research in global ophthalmology of trainees and early career investigators. The
mission of the Global Ophthalmology Summit is in alignment with the National Eye Institute’s new strategic
plan to drive innovative vision research, foster collaboration, build global research consortia, inspire and recruit
a diverse workforce, and educate our community and policymakers on the pressing needs of vision research.
The National Eye Institute’s cross cutting areas of research emphasis addressed in past and future Summits
include genetic research, data science, individual quality of life, and public health and disparities research.

Public health relevance
PROJECT NARRATIVE The Global Ophthalmology Summit is an annual meeting that bring together a multi-disciplinary group of experts dedicated to advancing eye health globally through research, clinical care, education, and policy to prevent blindness worldwide. The project objective is to support innovative vision research in global ophthalmology of medical students, trainees, and early career investigators. The Global Ophthalmology Summit provides an opportunity to captivate this young audience and will lay the foundation for future collaborations, mentorship, and inspire a career in vision science.